Imaging neural, astrocytic and vascular synchronization to assess cocaine's effects on mPFC

This application, "Imaging neuronal, astrocytic and vascular synchronization to assess cocaine’s effects
on mPFC", responds to NIDA’s CEBRA program to ‘develop or adapt innovative techniques for addiction
research’. The central goal of this proposal is to develop a novel artificial intelligence (AI) enhanced
fluorescence and optical Doppler microscope (AI-flODM) for simultaneous imaging of neuronal Ca2+
(Ca2+N) , astrocytic Ca2+ (Ca2+A) activities and cerebral blood flow velocity (CBFv) in medial prefrontal cortex
of awake animals. AI frameworks will be used to effectively minimize motion artifacts, denoise and segment
time-lapse images, from which spatiotemporal analyses will be applied to derive the synchronized Ca2+N,
Ca2+A, and CBFv activities characterized by their resting-state low-frequency oscillations (LFOs, <1Hz) in
mPFC of awake animals (Aim 1). AI-flODM will be used to assess cocaine’s effects on Ca2+N, Ca2+A, and
CBFv LFOs in mPFC of naïve mice and mice exposed to chronic cocaine, and chemogenetics (DREADDs)
will be used to determine Ca2+A in mediating cocaine-induced Ca2+N and CBFv synchronization (Aim 2).
An interdisciplinary research team has been assembled, including biomedical engineers, neuroimaging
scientists, and computer scientists to conduct the proposed research and development. This application
will be valuable for exploring the interactions in astrocytic signaling, neuronal excitability and local
microvascular responses involved in mPFC function and in their changes elicited by cocaine. The broad
impact of this application will be to provide a tool to complement other neuroimaging modalities to measure
neuronal, astrocytic, and vascular aspects of brain function in awake animals.

Public health relevance
We propose to develop artificial intelligence (AI) enhanced fluorescence and optical Doppler microscope for imaging of astrocytic Ca2+ (Ca2+A), neuronal Ca2+ (Ca2+N) activities and cerebral blood flow velocity (CBFv) of awake animals. AI frameworks will be used to effectively minimize motion artifacts and denoise time-lapse images, from which spatiotemporal analyses will be applied to derive Ca2+A, Ca2+N, CBFv synchronization via their resting-state low-frequency oscillations (<1Hz) in medial frontal cortex (mPFC) of naïve mice and mice with chronic administration of cocaine. Successful completion of the proposed research and development will have a broad impact on neuroscience and drug addiction that require high-resolution, simultaneous imaging of neuro- astroglio-vascular effects in the brain of awake animals. This translational research is of clinical relevance to drug addiction – a highly prevalent public health problem.